THE NATIONAL CANCER INSTITUTE'S CONTACT CENTER

The objective of this contract is to perform all activities required to run the National Cancer Institute's Cancer Information Service Contact Center. The National Cancer Institute's (NCI's) Cancer Information Service (CIS) is a federally funded program that was established in 1975 as an essential part of NCI's cancer education and information efforts. For over 35 years, NCI's CIS has been providing scientifically based, unbiased information to patients, their families and friends, physicians and other health professionals, and the general public about all aspects of cancer.